Identifying tandem repeat expansion-mediated mechanisms of autism-risk genes

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Autism spectrum disorder (ASD) is a set of neurodevelopmental conditions that affect communication and social interactions with restricted interests and repetitive behaviors. Although ASD has one of the highest heritability rates of all complex disorders, and hundreds of genes are known to confer a risk for this condition, most ASD cases remain idiopathic. A critical barrier to progress in the field is to identify additional ASD-risk genes. Since most of the known ASD variants are biased toward coding regions, an unmet need is to evaluate the contribution of noncoding sequences in ASD etiology, including tandem repeats (TRs) that account for ~5% of the human genome. Recently two independent large-scale genome studies uncovered previously undetected and predominantly noncoding TR mutations that have been suggested to account for ~4% of idiopathic ASD cases. Although these studies opened uncharted territory by revealing numerous TR expansion mutations (TRexp) in ASD, they were underpowered to adopt the required statistical rigor to select gene candidates for further mechanistic studies. To overcome this critical barrier to progress in the field, we designed a framework to investigate the contribution of noncoding TRexp in ASD etiology. Based on our considerable expertise in complex TRexp disease mechanisms, we propose to test the central hypothesis that ASD-associated noncoding TRexp contribute to ASD etiology by inducing pathogenic gene regulatory mechanisms that have been documented in other TRexp disorders. We will test our central hypothesis by: (i) identifying high-confidence ASD-risk genes with TRexp enriched in the ASD population (Aim 1); (ii) selecting TRexp based on their propensity to perturb high-confidence ASD-risk gene transcript processing (Aim 2); (iii) testing the hypothesis that intronic TRexp alter specific regulatory steps during ASD-risk gene RNA processing (Aim 3). The results of this proposal will transform our understanding of ASD by addressing important problems underpinning critical barriers to progress in the field by: (i) providing a new approach to identify high-confidence ASD-risk genes from underpowered studies; (ii) developing specialized criteria to estimate TRexp propensity to perturb ASD-risk gene expression and RNA processing patterns; (iii) spanning the bridge between genomic TRexp findings in the ASD population and their mechanistic basis.

Public health relevance
The goal of this project is to identify tandem repeat expansion mutations in high confidence autism-risk genes. We will elucidate the molecular mechanisms induced by these mutations and demonstrate the adverse effects on their host genes. Therefore, this project will profoundly impact our understanding of autism and will inform future biomarker and therapeutic strategy development.